Characterization of lectins to understand human microbiome functions and develop live biotherapeutics

Project Summary
Almost all living cells use specific non-enzymatic carbohydrate binding proteins (e.g. lectins) to recognize
carbohydrate ligands for cellular trafficking, signaling and defense. The systematic study of lectins and their
carbohydrate ligands has improved our understanding of human health and the high specificity of lectins for
certain cellular interactions has made them a valuable resource for therapeutic discovery. In previous research,
my laboratory suggested that human commensal microbiota utilize lectins (e.g. human-microbial-lectins) to
regulate a complex network of host-microbe interactions beyond those mediated by simple pattern recognition
receptors and conserved microbial metabolites. Furthermore, our characterization of a highly prevalent human-
microbial-lectin Cbeg5 suggests this specific lectin may regulate fundamental human myeloid cell interactions
integral to normal microbiome homeostasis. As such, the central hypothesis of this proposal is that the study
of Cbeg5 and other human-microbial-lectins will elucidate microbiome functions relevant to human health and
which can be developed therapeutically. We will advance this hypothesis through three aims to define (1) how
Cbeg5 regulates distinct myeloid cell populations, (2) the potential to develop Cbeg5 as a therapeutic for
inflammatory bowel disease, and (3) to explore the larger network of microbiome interactions regulated by
human-microbial lectins.

Public health relevance
Project Narrative All living cells use carbohydrates and carbohydrate binding proteins (e.g. lectins) to interact with its environment but despite the importance of lectins to human pathophysiology and for therapeutic development, the study of lectins made by bacteria that live inside humans (i.e. commensal bacteria) has been limited. In this proposal we will (1) study how a lectin made by a commensal bacteria regulates intestinal immune cells, (2) explore the therapeutic potential of this lectin to treat inflammatory bowel disease and (3) begin mapping the network of host- microbe interactions mediated by lectins produced by human commensal bacteria. These aims will improve our understanding of how the human microbiome contributes to disease and develop novel therapeutic strategies.